The role and mechanism of METTL3/METTL14-mediated RNA modification in the pathogenesis and drug-resistance of AML

PROJECT SUMMARY (ABSTRACT):
Background: N6-methyladenosine (m6A) modification is the most abundant internal modification in
eukaryotic messenger RNAs (mRNAs) and plays critical roles in various normal bioprocesses. Evidence is
emerging that m6A and the associated machinery also play roles in cancers. Acute myeloid leukemia (AML) is
one of the most common and fatal forms of hematopoietic malignancies with distinct cytogenetic (e.g., MLL-rearranged)
and molecular (e.g., mutations in FLT3 and NPM1) abnormalities. Over 70% of AML patients cannot be cured by
contemporary therapies due to drug resistance and relapse. The leukemia stem/initiating cells (LSCs/LICs) are
considered to be the root cause for the treatment failure and relapse of AML. Thus, it is critical to better understand the
molecular mechanisms underlying AML pathogenesis, LSC/LIC self-renewal and drug resistance, which may lead to
the development of effective novel therapeutic strategies to treat AML. RNA m6A modification is deposited by the
METTL3-METTL14 methyltransferase complex (MTC; i.e., writer), and may affect the stability and/or translation
efficiency of target mRNAs. We and others have reported that both METTL3 and METTL14 play oncogenic roles
in MLL-rearranged AML, but their definitive roles in the development and maintenance of other (i.e., non-MLL-
rearranged) subtypes of AMLs and especially in LSC/LIC self-renewal remain elusive. Our unpublished
preliminary data imply that METTL3 and METTL14 may also play roles in drug resistance in AML, which warrants
further systematic studies. Furthermore, their critical targets in AMLs have yet to be well investigated.
Hypothesis: METTL3 and METTL14 play essential oncogenic roles in AML pathogenesis, LSC/LIC
maintenance and drug resistance through m6A-dependent regulation of expression of critical target genes.
Specific Aims: 1) To determine the roles of METTL3 and METTL14 in the development and maintenance
of different subtypes of AMLs, as well as in the self-renewal of relevant LSCs/LICs and normal HSCs; 2) To
determine the roles of METTL3 and METTL14 in drug resistance of AMLs; and 3) To decipher the molecular
mechanisms underlying the pathological roles of METTL3 and METTL14 in AML development/maintenance,
LSC/LIC self-renewal and drug resistance.
Study Design: 1) We will use inducible Mettl3 and Mettl14 knockout mouse models coupled with mouse
AML models, as well as patient-derived xeno-transplantation (PDX) models, to investigate the roles of METTL3
and METTL14 in development/maintenance of different subtypes of AMLs and self-renewal of LSCs/ LICs and
normal hematopoietic stem cells (HSCs). 2) We will conduct both gain- and loss-of-function in vivo studies to
determine whether METTL3 and METTL14 play critical roles in drug resistance of AMLs. 3) We will perform PAR-
CLIP-seq, m6A-seq, RNA-seq, RNA life-time profiling-seq, and ribosome profiling-seq to identify all direct targets
of METTL3 and METTL14 in AMLs and to understand how METTL3 and METTL14 regulate expression of their
target RNAs, followed by validation and functional studies of a set of top candidate targets.

Public health relevance
Project Narrative: The major goal of this proposal is to investigate the roles and underlying mechanisms of METTL3 and METTL14, two proteins that compose N6-methyladenosine (m6A; a major type of modification in messenger RNA) methyltransferase (or called “writer”) complex, in the development and maintenance of different major subtypes of acute myeloid leukemias (AMLs; one of the most common and fatal types of hematopoietic malignancies) and in the maintenance of the relevant leukemia stem/initiating cells (LSCs/LICs), as well as in drug resistance/response. Thus, the success of this project will provide profound novel insights into the biological functions and the underlying molecular mechanisms of m6A modification and the critical components of the m6A machinery (i.e., METTL3 and METTL14) in leukemia biology, which will shed new light on the molecular mechanisms underlying leukemia pathogenesis, LSC/LIC maintenance, and drug resistance/response, and may also lead to the development of effective novel therapeutic strategies to treat AMLs. Therefore, our project is of great significance in both basic research and translational research.